Characterizing neurocognitive deficits in post-acute sequelae of COVID-19

ABSTRACT
Post-acute sequelae of COVID-19 (PASC), or Long COVID, is an emerging global health crisis with an urgent
need for objective assessment tools to quantify neurocognitive deficits. This proposal aims to validate and
leverage a novel mobile electroencephalography (EEG) platform to provide accessible, cost-effective cognitive
assessments for individuals suffering from neurological manifestations of PASC (nPASC).
Our preliminary data suggests that EEG/event-related potential (ERP) biosignatures, including delayed neural
responses during auditory and memory tasks, are sensitive to cognitive impairments in nPASC. However, the
trajectory and specificity of these deficits remain unclear. This study will validate these preliminary findings in a
larger cohort (n=52) and longitudinally monitor changes over one year to map recovery or detect early signs of
persistent cognitive decline.
The innovative approach integrates resting-state EEG with multiple task-based ERP protocols, enabling
comprehensive profiling of neural dysfunction associated with nPASC. Leveraging Advanced Brain Monitoring's
FDA-cleared mobile EEG platform and validated analysis pipelines will provide a scalable solution for
widespread clinical use and remote assessments.
If successful, this study will deliver a quantitative EEG/ERP biomarker profile specific to neuro-PASC, enabling
objective evaluation of cognitive deficits. Longitudinal monitoring will elucidate the natural trajectory, identify
potential risk factors for persistent impairment, and provide outcome measures for future therapeutic
interventions. This innovative diagnostic tool will empower patients and clinicians by providing objective
evidence of nPASC severity and treatment efficacy.

Public health relevance
NARRATIVE Our research endeavor is designed to establish a reliable and quantitative EEG/ERP biomarker profile tailored for the neurologic manifestations associated with post-acute sequelae of SARS-CoV-2 infection (PASC), colloquially known as Long COVID. This condition drastically diminishes individuals' quality of life and is emerging as a significant public health issue. By harnessing the advancements in mobile EEG technology, our approach intends to introduce an accessible, cost-efficient, and scalable method for cognitive evaluations suited for patients with neurologic involvement in PASC. This initiative will pioneer a pathway for the practical assessment of cognitive impairments, furnishing both healthcare professionals and patients with precise metrics to gauge symptom severity and track the progress of therapeutic interventions effectively.